Gene therapy for Alzheimer's disease using virally delivered Aβ variants

SUMMARY
The continuing saga of anti-Ab antibody aducanumab has produced the first positive phase 3 outcome for
Alzheimer's disease (AD) since memantine was approved in 2003. This promising, albeit controversial, result
has breathed new life into the therapeutic potential for Ab-lowering strategies and legitimized the ongoing
exploration of other means to chronically and safely mitigate Ab. Past work had shown that small peptide
inhibitors can be readily tailored to prevent Ab aggregation, but in vivo delivery of peptide-based drugs was
limited by short half-life and poor brain penetration. We have identified two Ab sequence variants that meet
criteria for potential therapeutic use, as they 1) prevent aggregation of WT Ab in vitro, 2) promote disassembly
of Ab existing fibrils, 3) mitigate toxicity of Ab oligomers, and importantly, 4) do not self-aggregate. To deliver
these peptides in vivo, we have developed a novel mini-gene to express our variant peptides at the plasma
membrane where they are released into the extracellular space by g-secretase cleavage. By packaging this
minigene into an AAV vector that is injected into APP/PS1 mice, our pilot data show that viral expression of
variant Ab lowers Ab load and delays plaque formation. The current proposal will build on these results
through the following specific aims. First, we will decipher the biophysical mechanism of interactions between
variant and wild type Aβ peptides. We will use analytical methods of CD spectroscopy, SEC chromatography,
EM, and antibody profiling to define the structural mechanism by which our variants prevent/reverse
aggregation of wild-type Ab. Second, we will determine how dosage, timing and route of variant Aβ
administration influence efficacy in vivo. We will use viral strategies to compare interventional treatment after
amyloid onset with preventative treatment starting at birth, determine the lowest effective ratio of variant:wild-
type Ab needed to modify plaque formation and cognitive function, and test whether delivery through the CSF
can match the effect of neuronal transduction. Third, we will interrogate the neuroimmune reaction to variant
Aβ as an accomplice to plaque reduction. We will use histological and transcriptional profiling to assess
whether a neuroimmune response to either the variant peptide or its AAV carrier contribute to plaque
prevention in vivo, and if the neuroimmune response changes with age. Finally, we will test the potential for
variant Aβ to slow AD aggregate seeding. We anticipate that variant Ab will slow seeding by AD Ab extracts,
but will more importantly test whether variant Ab can assuage cross-seeding of tau in amyloid-bearing mice. If
successful, this strategy for self-inhibition may also be applicable to other protein misfolding diseases where
peptide treatments have been eschewed for technical reasons that can now be overcome through
expression engineering and viral technology.

Public health relevance
NARRATIVE This proposal will explore the idea that a modified version of the Ab peptide might be used therapeutically to block aggregation of the wild-type peptide. Our study endeavors to identify the biophysical mechanism of inhibition and to test a gene therapy vector for delivery of variant Ab in mouse models. We intend this work to serve as a framework for exploring peptide self-inhibition in Alzheimer's disease and other disease-associated aggregation disorders.